Understanding the physiology and pathophysiology of kidney-derived vasopressin

Chronic Kidney Disease (CKD) affects 15% of the US adult population30 and vasopressin is
associated with progression of non-diabetic, diabetic, and polycystic kidney disease (PKD). 1-18
However, the specific mechanism(s) through which vasopressin worsens progression of kidney
disease are unclear. Vasopressin is the biologically active end-product of a 164 amino acid pre-
pro-peptide and physiologic production is currently thought to be limited to the brain. We
recently found that vasopressin is also made in the kidney under physiologic conditions and
expression is increased in PKD in both humans and mice. Therefore, the aim of this project is to
understand the function, regulation, and impact of kidney-derived vasopressin in health and
disease. We have preliminary data that show that mice that lack kidney-derived vasopressin in
the distal nephron have altered water balance. We propose to (1) determine the mechanism
through which kidney-derived vasopressin influences water balance and (2) determine if kidney-
derived vasopressin is involved cyst growth and progression of PKD. Successful completion of
this project will help clarify the mechanism(s) through which the interplay between local and
systemic vasopressin signaling impacts kidney disease, potentially identifying new therapeutic
targets and approaches for CKD and PKD. Work will occur in one of the largest and most
scientifically diverse nephrology divisions in the world, within the Vanderbilt University Medical
Center Department of Medicine. This project has already received extensive external (Harold
Amos Medical Faculty Development Award – 2020) and institutional support in the form of
financial support and a comprehensive career development plan involving internal and external
mentorship, workshops, and coursework.

Public health relevance
Vasopressin is a hormone that regulates water balance, blood pressure and contributes to progression of non-diabetic, diabetic, and polycystic kidney disease (PKD), through mechanisms that are still unclear. Vasopressin production was thought to be limited to the brain, but we have evidence that it is also made in the kidney. This project aims to understand the role that kidney-derived vasopressin plays in health and disease using cells and transgenic mouse models with a targeted deletion of vasopressin in the kidney.